ICU-CARE: An interactive mobile app to enhance the efficiency of daily informal caregiving in the intensive care unit

PROJECT SUMMARY
Actively involving informal caregivers in direct patient care at the bedside in the intensive care
unit (ICU) has the potential to improve patient, informal caregiver, and health care system
outcomes. Practice guidelines call for the liberal inclusion of informal caregivers as active
partners in ICU care, but there is a critical, unmet need to develop tools that effectively
operationalize safe and effective caregiver involvement. Our solution, ICU-CARE employs a
user-centered design, providing informal caregivers with: 1) a virtual tour and education specific
to the ICU environment, 2) interactive educational modules that teach caregivers how to assess
and manage common symptoms of ICU patients with evidenced-based nonpharmacologic
interventions, and 3) an electronic platform for caregivers to record and track their contributions
to patient care. The long-term goal of this STTR project is to commercialize an easy-to-use
mobile application that improves the efficiency of day-to-day informal caregiving, facilitates
symptom management decisions, and enhances clinical communication among patients,
caregivers, and health care providers in the ICU. In Phase I, we will revise and optimize ICU-
CARE (Aim 1) by analyzing data from current users of the ICU-CARE alpha version to identify
the essential elements of the graphical user interface and educational content. We will use our
findings to create a beta version. For Aim 2, we will integrate ICU-CARE with our electronic
health record (EHR) system by creating an application programing interface (API). Finally, in
Aim 3, we will recruit a purposeful sample of ICU informal caregivers and ICU nurses to
participate in task-driven simulations to evaluate preliminary usability, feasibility, and
acceptability of ICU-CARE, as well as validate our API connection within an EHR test
environment. In Phase II, the team will conduct a fully powered two-group feasibility randomized
controlled trial of ICU-CARE versus attention control with a 1-month follow-up. Results from this
trial will further determine the app’s feasibility and acceptability as well as test efficacy. The
commercial opportunity lies in becoming the standard of care for addressing patients’ symptom
needs as well as improving the effectiveness of informal caregiving for over 5 million ICU
patients and caregivers per year in the United States.

Public health relevance
PROJECT NARRATIVE The objective of this STTR is to enhance ICU-CARE, a mobile app that promotes informal caregiver participation in patient care in the intensive care unit (ICU). Our solution is expected to improve the effectiveness of day-to-day informal caregiving, facilitate symptom assessment and management decisions, and support care communication for over 5 million ICU patients and their informal caregivers.